ALZHEIMER'S DISEASE

This protocol was phased-out at the beginning of this grant year. No research subjects were admitted to the GCRC. The previously stored cell lines were distributed back to the investigators.